Environmental Assessment for Oxytetracycline Dihydrate Administered to Shrimp for Minor Use Minor Species

Summary/Abstract
PAHC is seeking approval from the U.S. Food and Drug Administration (FDA) Center for
Veterinary Medicine (CVM) of Terramycin® 200 for Fish Type A medicated article,
containing the active pharmaceutical ingredient (API) oxytetracycline, for use in penaeid
shrimp. The proposed indication is for the control of mortality in penaeid shrimp due to
necrotizing hepatopancreatits (NHP) associated with Hepatobacter penaei. The work
involved will include environmental assessment, conditions of use of the drug, exposure
assessment, effects assessment, risk characterization, and conclusions.

Public health relevance
Project Narrative Phibro Animal Health Corporation (PAHC) proposes to prepare an Environmental Assessment (EA) to support the use of Terramycin® 200 for Fish (oxytetracycline dihydrate) Type A medicated article (NADA 038-439) for the control of mortality in penaeid shrimp due to necrotizing hepatopancreatitis associated with Hepatobacter penaei, where PAHC has selected Exponent to assist them in the preparation of the EA. The EA will be prepared following the recommendations in the Phase I Environmental Impact Assessment guidance (Guidance for Industry [GFI] 89) or Phase II Environmental Impact Assessment guidance (GFI 166). The potential environmental issues identified for this drug product, and the approaches used to evaluate whether the identified potential environmental issues are significant will be described.